Identifying Functional Drivers of MYC Activation via Developmental Enhancers in Diffuse Large B-cell Lymphoma

PROJECT SUMMARY / ABSTRACT
Overexpression of the oncogene MYC is characteristic of most high-risk diffuse large B-cell lymphomas, and is
essential for the survival of lymphoma models. However, only half of DLBCLs assigned to high-risk subgroups
of germinal center-like (GCB)-DLBCL by gene expression profiling bear activating genomic rearrangements of
MYC, and MYC rearrangements are even less frequent in another common high-risk subtype, ABC-DLBCL.
There is currently a poor understanding of the mechanisms that lead to MYC transcriptional dysregulation in
DLBCL in the absence of an activating genomic rearrangement between MYC and an immunoglobulin gene
locus (MYC-IG). The overall objective of this proposal is to define novel mechanisms of MYC regulation by distal
enhancers. Our long-term goal is to use this understanding to develop improved therapeutic strategies and / or
predictive biomarkers for DLBCL patients. Our working hypothesis is that transcriptional activation of MYC
required to sustain DLBCL is dependent on the cis-regulatory activity of a small number of essential distal
enhancer modules, located within much larger “super-enhancer” regions. These modules are located either
within the 3’ region of the MYC locus on 8q24 (in DLBCL without MYC rearrangement), or in a genomic
rearrangement partner locus such as 3q27, which is among the most common non-IG MYC rearrangement
partners. We will utilize high-throughput CRISPR-interference profiling to perform robust functional interrogation
of complex, multi-modular “super-enhancers” present in 8q24 and 3q27 in DLBCL cell lines that lack MYC
rearrangements (Aim 1), or bear t(3;8)(q27;q24) rearrangements (Aim 2) respectively. Having identified the
discrete distal enhancer elements that are required for MYC activation, we will utilize a complementary set of
experimental approaches, including genetic deletion or mutation of enhancer sequences, chromatin
immunoprecipitation, reporter assays, in vitro DNA-protein binding assays, and perturbation of trans factors and
upstream pathways to characterize the regulation of these elements. Our preliminary data suggests that distinct
enhancer modules within the 3’ MYC enhancer region are essential for DLBCLs with different aberrations
affecting trans factors that selectively bind the essential enhancer modules. These aberrations include diverse
signaling and genetic events that activate NF-kB factors, or alternately, hyperactivation of the coactivator OCA-
B and a set of synergistically acting developmental transcription factors. We will evaluate the extent to which
MYC activation in the context of a t(3;8) rearrangement is dependent on “hijacking” of MEF2B-regulated
enhancer modules that are typically responsible for activation of the oncogene BCL6. Upon successful
completion of the proposed research, we expect to rigorously define multiple distinct mechanisms by which
enhancers and associated trans-factors can drive MYC transcriptional activation in DLBCL. Our innovative
approach for identifying the key mechanisms underlying oncogene activation by complex multi-modular distal
enhancers may serve as a model for similar investigations in a wide variety of cancer types.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because MYC dysregulation is a common feature of “high risk” diffuse large B-cell lymphoma subtypes that frequently recur after standard first-line chemotherapy. Understanding the mechanisms that lead to MYC transcriptional dysregulation in the absence of well-understood MYC-immunoglobulin gene rearrangements could lead to improved biomarkers for diagnosis of high-risk disease, and ultimately to novel therapeutic strategies for lymphoma patients.